Role of the proton channel OTOP1 in taste transduction

PROJECT SUMMARY
The broad goal of the proposed experiments is to identify key molecules that allow mammals to detect basic
taste stimuli and generate electrical responses. Taste stimuli are detected by taste buds located on the tongue
and oral cavity that contain distinct cell types, including the Type III taste receptor cells (TRCs) generally believed
to mediate sour taste. Molecular mechanisms of taste reception have been a subject of intense investigation
over the last 30 years, with great strides made in identifying receptors for bitter, sweet, umami and sodium taste.
The receptor for sour taste was more elusive. In the last two grant periods, we identified Otop1 as a candidate
sour receptor, and showed that it encoded a novel proton-selective ion channel (OTOP1), expressed in Type III
TRCs. Our results from the last grant period showed that in Otop1 knockout mice (Otop1-/-) responses of isolated
taste receptor cells and of the gustatory nerve to acids were strongly attenuated, confirming a key role of OTOP1
in sour sensing. However, we found no change in taste behavior to acid stimuli in Otop1-/- mice. In addition to
acid stimuli, Type III TRCs also respond to high concentrations of salts. Of these, ammonium chloride, a
breakdown product of amino acids that is a strong taste stimulus, is known to change the pH of the cell cytosol.
In the last grant period we showed, quite unexpectedly, that OTOP1 is strongly activated by ammonium chloride,
through a mechanism distinct from the pH-gating observed in response to acid stimuli. We also showed that
gustatory nerve responses and behavioral aversion to ammonium chloride are attenuated in Otop1-/- mice.
These results lead us to hypothesize that OTOP1 functions as a general pH sensor in the gustatory system,
where it mediates response to taste stimuli that change extracellular or intracellular pH. We test this hypothesis
through three aims. The first aim is focused on identifying pharmacological tools that can be used to activate or
inhibit OTOP1 channels using a structured-guided virtual screen and patch clamp recording of heterologously
expressed OTOP1 channels. Successful completion of this aim will provide new tools to assess the contribution
of OTOP1 to the detection of other taste stimuli under Aims 2 and 3, complementing experiments with Otop1-/-
mice. Aims 2 and 3 examine the contribution of OTOP1 to the detection of two stimuli previously shown to be
mediated by Type III TRCs, water, and carbonation, using patch clamp recording of HEK-293 cells expressing
OTOP1 channels and isolated taste receptor cells (Aim 2) and gustatory nerve recording, swallowing and taste
behavior (Aim 3). The successful completion of these aims will lead to a comprehensive understanding of the
mechanisms by which Type III taste receptor cells detect a wide range of non-canonical taste stimuli. The
identification of taste modifiers may be used to enhance palatability of food, reducing the need to add sweeteners
that contribute to the development of diabetes or salts that contribute to hypertension.

Public health relevance
PROJECT NARRATIVE The proposed experiments will use a multi-pronged approach to understand the contribution of the newly identified OTOP1 proton channel to taste signaling, and to develop tools with which to modulate OTOP1 activity. OTOP1 is the founding member of a new family of ion channels, whose functions are largely unknown. Taste plays a defining role in dietary choice, and thus identification of taste receptors has the potential to improve human diet and thereby combat diseases such as obesity or hypertension.